BV-ARA-U VS ACYCLOVIR IN LOCALIZED HERPES ZOSTER IN IMMUNOCOMPROMISED PTS

This is a randomized, double-blind, controlled trial to compare the efficacy of BV-ara-U (40mg/d) versus acyclovir (800 mg five times daily) in the treatment of acute, localized, non-trigeminal zoster in immunocompromised patients.